SECRETION OF HYPOTHALAMIC AND PITUITARY HORMONES

Using microcannulation procedures, we propose (1) to investigate under in vivo conditions the mechanisms whereby anterior and posterior pituitary hormones are secreted into pituitary stalk blood resulting in super-high concentrations in stalk plasma of LH, FSH, TSH, prolactin, ACTH, alpha-MSH, and vasopressin; (2) to determine the role of posterior pituitary hormones in the control of anterior pituitary hormone secretion; (3) to investigate the role of thyroid hormones, gonadal steroids, and adrenal steroids in the secretion of pituitary hormones into stalk blood; (4) to investigate the significance of retrograde blood flow in the pituitary stalk in the delivery of pituitary hormones to, and their transport across, the median eminence and hence to the brain; (5) to determine the mechanisms involved in the hypothalamic secretion of LHRH, TRH, and dopamine into hypothalamic-hypophysial portal blood. Using in vitro conditions, we propose (1) to characterize the subcellular compartmentalization of LHRH, TRH, and alpha-MSH in synaptosome-like particles, hereafter called synaptosomes, prepared from hypothalamic homogenates; (2) to investigate the mechanisms involved in the storage and release of LHRH, TRH, and alpha-MSH from synaptosomes; (3) to test the hypothesis that Ca 2 ion in the presence of depolarizing concentrations of K ion causes TRH, LHRH, and alpha-MSH release from synaptosomes by activating guanylate cyclase and/or adenylate cyclase, thereby forming cGMP and/or cAMP; (4) to investigate the role of synaptosomal microtubules, tubulin, and microfilaments in the exocytosis of TRH, LHRH, and alpha-MSH; (5) to investigate the role of prostaglandins, viz., PGE2 and PGF2 alpha, prostaglandin precursors, and phospholipids enriched with arachidonic acid and lysophospholipids in the release of TRH, LHRH, and alpha-MSH from synaptosomes.